Understanding general principles in receptor tyrosine kinase signaling through structural and functional studies

Abstract
Receptor tyrosine kinases (RTKs) are a large family of single-pass transmembrane cell surface receptors
that play key roles in normal cellular processes and are linked with many human diseases. In general, the
ligand binding to the extracellular region of RTKs induces receptor dimerizaƟon and acƟvaƟon, but many
RTKs cannot be acƟvated simply by ligand-induced dimerizaƟon. In the past 5 years, my lab has performed
extensive structural (cryo-EM) and funcƟonal invesƟgaƟons of several special RTKs, including the IR, IGF1R,
IRR, c-MET, RET, and MuSK. Each of the RTK stories from my lab individually deﬁnes how an important RTK
is acƟvated through a unique mechanism. However, many quesƟons regarding the acƟvaƟon and
regulaƟon of RTKs remain unanswered. Firstly, to date, none of the cryo-EM structures were able to resolve
a complete structure of any RTKs, due to the ﬂexible linkages of the TM with both the ECD and ICD.
Therefore, how the conformaƟonal changes are coupled between the extracellular, transmembrane and
intracellular regions remain unclear. Secondly, some RTKs are capable of triggering disƟnct downstream
pathways when acƟvated by diﬀerent ligands. These issues of signaling speciﬁcity and biased agonism are
criƟcal to RTK funcƟon in vivo, but are not understood in physical terms. Thirdly, many RTKs such as TAM,
epidermal growth factor receptor (EGFR) and Eph receptors form large clusters upon acƟvaƟon, but the
underlying mechanisms are poorly understood. Our future research will be centered on answering these
quesƟons, in order to deﬁne the general working principles of RTKs. Our innovaƟve approach combines
biochemistry, biophysics, cell biology, ligand engineering, and cryo-EM. Finally, understanding the
structural basis for the RTK acƟvaƟon and regulaƟon will enable us to design new therapeuƟcs to treat
diseases that are caused by malfuncƟons of RTKs.

Public health relevance
NarraƟve By integraƟng single-parƟcle cryo-EM, alongside biochemical and cell-based approaches, we aim to comprehensively explore the structures and funcƟons of ligand-bound full-length receptor tyrosine kinases (RTKs) in both dimeric and higher-order conﬁguraƟons. This will unveil novel insights into the molecular processes that govern RTK acƟvaƟon and regulaƟon, while also deciphering the mechanism underlying biased signaling.